Washington National Primate Research Center

SUMMARY/ABSTRACT
This proposal is a request to purchase and install collapsible pen housing for groups of nonhuman primates that
support the NIH priorities for HIV-related research. HIV-related research often involves long term housing of
macaques that can last for up to years. Currently these animals are housed in pairs in socialization cages. To
improve socialization opportunities, provide a more complex housing environment, and increase enrichment we
aim to institute group housing in pens for animals on HIV/AIDS projects. Housing these animals in pens rather
than individual cages improves overall animal welfare in two ways: Socialization in groups provides significantly
improved psychological well-being when compared to single housing or even pair housing, and the increased
total space (horizontal and vertical) in pens compared to cages improves both physical and psychological well-
being.
One challenge to housing research animals in pens is the need to access animals for research procedures or
sampling. The proposed pens are designed to attach to one-over-one caging enclosures on both sides. Animals
will be trained to enter these enclosures voluntarily. Once within the enclosures, noninvasive samples may be
obtained voluntarily, or animals may be sedated for other procedures as required.

Public health relevance
PROJECT NARRATIVE We propose to purchase pens with adjoining enclosures for macaques assigned to HIV/AIDS research projects in our Seattle facility. Housing in pens will increase animal welfare, thus improving the research model. Animals will be trained to enter the adjoining cages voluntarily, allowing access for research or clinical procedures.